Identifying TB transmitters in high TB/HIV burdened communities

ABSTRACT
Tuberculosis (TB) is caused by Mycobacterium tuberculosis (Mtb), an obligate human pathogen whose
persistence within the human population depends on the ability to drive successive cycles of transmission,
infection, and disease. Consistent with its importance in maintaining elevated TB prevalence rates, there is
renewed interest in the potential for novel interventions to interrupt Mtb transmission in endemic regions. While
attractive, this approach requires rapid, reliable, and scalable technologies to detect live bacilli released by Mtb-
infected individuals independent of TB symptoms. This is a challenging undertaking given the practical and
biosafety difficulties posed by working with often paucibacillary samples of an infectious pathogen increasingly
associated with drug resistance. For this reason, most studies to date have focused on smear-positive TB
disease, thereby ignoring the potential contribution of sub-clinically infected individuals (i.e., those who are
minimally symptomatic or even asymptomatic) to Mtb transmission. In attempting to address this limitation, we
recently described the development and preliminary validation of the Respiratory Aerosol Sampling Chamber
(RASC), a personal clean-room equipped with advanced, high-efficiency filtration, sampling, and particulate
detection technologies that allows biosafe, non-invasive capture and isolation of live Mtb bacilli from confirmed
TB patients during normal respiratory activity; that is, without the requirement for induced cough. Building on the
postulate that the number of viable Mtb bacilli produced per unit of exhaled bioaerosol provides a reliable
measure of TB transmission potential, we propose here to optimize the RASC platform for rapid, semi-
quantitative detection of viable Mtb bioaerosols in large numbers of individuals. Existing, well-defined cohorts of
subjects will be screened to identify the proportion and infectiousness of Mtb transmitters and, importantly, will
be extended beyond smear-positive TB cases – a first for direct studies of Mtb transmission. Results will be
stratified by HIV status and used to model the contribution of sub-clinical Mtb transmission to TB prevalence
rates, in turn informing the design of implementable interventions to reduce the TB burden in endemic TB/HIV
settings. Finally, this approach also suggests the potential to use the RASC to understand the impact of TB
chemotherapy on Mtb bioaerosol release.

Public health relevance
PROJECT NARRATIVE Tuberculosis can be spread by symptomatic TB cases, those who have not yet developed symptoms and apparently well individuals. Our sampling of exhaled breath can identify and quantify prevalent TB infectious individuals. We use bioaerosol sampling of TB cases, TB suspects and people living with HIV to establish their relative contribution to TB transmission in a setting of highly endemic HIV and TB.